Uncovering the ultrastructure and connectivity of murine fungiform taste buds

Project Summary
Taste buds are the end organs of the gustatory system and allow for the detection of sweet, bitter, umami,
salty, and sour stimuli. In mammals, taste buds inhabit several areas of the oral cavity, including the fungiform
papillae of the anterior tongue and the circumvallate papillae of the posterior tongue. Two separate taste
nerves innervate the anterior and posterior tongue; the chorda tympani branch of the facial nerve innervates
the fungiform taste buds, while the glossopharyngeal nerve innervates the circumvallate taste buds. While
buds from both fungiform and circumvallate tissues can detect the five established taste qualities, several lines
of evidence suggest differences between anterior and posterior taste buds in both form and function (Travers
et al., 1987; Ninomiya & Funakoshi, 1989; Frank 1991; Ninomiya et al., 1991; Spector & Grill 1992; Hellekant
et al., 1997; St. John & Spector, 1998; Tomchik et al., 2007; Yoshida et al., 2009; Lewandowski et al., 2016).
Most of the anatomical taste bud data in the literature feature only the circumvallate taste buds—this is likely
due to the relative ease of isolating taste buds from the closely packed buds of the circumvallate tissue rather
than the sparse buds of the fungiform tissue. The cellular composition of taste buds, detailed taste cell
morphology, and patterns of connectivity between taste cells and innervating nerve fibers have been reported
in circumvallate tissue (Romanov et al., 2018; Yang et al., 2020; Wilson et al., 2022). The current proposal
aims to close the anatomical knowledge gap across taste fields by examining fungiform taste buds via Serial
Block Face Scanning Electron Microscopy (sbfSEM). This high-resolution imaging technique can produce
serial electron micrographs through entire mouse fungiform taste buds. When aligned and imported into
specialized imaging software, objects in the mass of the taste bud can be manually traced and reconstructed in
digital 3D space. To augment the manual segmentation process, this project will also employ machine learning
techniques to identify and segment a portion of the objects of interest in the dataset. Using micrographs and
the 3-D reconstructions of objects therein, this project will unveil morphological details of fungiform taste cells.
It will reveal whether or not morphological subsets of the three established mature taste cells exist in fungiform
taste buds, and whether or not their morphologies differ from those described in the circumvallate. By
reconstructing the nerve fibers that receive synapses from fungiform taste cells, the proposed project will also
reveal the “connectome” of the fungiform taste buds. Anatomical patterns of connectivity between taste cells
and innervating nerve fibers underlie the taste information coding from taste bud to the central nervous system.
Understanding the connectome will thus provide new insight into how fungiform taste buds communicate taste
quality information to the brain, and whether their patterns of connectivity differ from those of circumvallate
taste buds. By elucidating and describing the morphological details and connectome of fungiform taste buds,
this project will expand our understanding of both form and function in the anterior tongue.

Public health relevance
Project Narrative The goal of the proposed research is to elucidate the cellular composition, detailed cellular morphology, and patterns of taste cell-to-nerve connectivity of murine fungiform taste buds. Several lines of evidence suggest that the fungiform taste buds of the anterior tongue might differ considerably from the circumvallate taste buds of the posterior tongue in both composition and function. A thorough examination of fungiform taste bud morphology would fill in a glaring gap in our anatomical understanding of the peripheral gustatory system in mammals.